Enhancing uptake of preconception care services in family practice clinics using a patient centered screening tool: A Pilot Study

Project Summary
Women who make positive health behavior changes to protect their fetus typically do so after learning about
the pregnancy, unaware that the period of maximum sensitivity to these changes has passed. Fewer than half
of mothers enter pregnancy at a healthy weight and an increasing percentage of pregnancies are affected by
chronic hypertension and other chronic health conditions. These risk factors are predictive of poor birth
outcomes and increased risk to maternal health, yet they are difficult to modify after conception. Routine
preconception screening and counseling is recommended for all women of reproductive age, yet adherence is
low. More than sixteen years after the CDC recommended routine preconception screening and counseling in
primary care settings, fewer than one-fifth of primary care providers conduct this critical screening. Pioneering
approaches are needed to increase preconception screening and improve patient adherence to preconception
recommendations in primary care settings. Our innovative, self-selected preconception screening tool
encourages patients to be active participants in their own care and eliminates the time burden associated with
typical pre-selected screening. Typical pre-selected risk screening tools ask patients a series of predetermined
health-related questions to identify health risks. Pre-selected tools identify health information needs for the
patient, based on the patient’s response to the risk assessment. We propose a patient-selected screening tool,
whereby the patient selects from a list of preconception counseling topics based on her own perceived need
for information. This tool has fewer questions, reducing time burden.The first specific aim of this project is to
compare topics identified for counseling and overall identification of risk between the two screening
approaches. The second aim is to compare preconception knowledge, behavior change intention and self-
efficacy between patients who receive patient-selected and pre-selected preconception screening. The third
aim is to utilize a QUAN-qual sequential mixed methods design to explain quantitative results and identify
novel options for preconception counseling. To accomplish this objective, we will conduct a pilot study in a mid-
size primary care clinic located in a Midwest urban setting. Female patients of child-bearing age will be
randomly assigned to receive: 1) pre-selected preconception screening; 2) patient-selected preconception risk
screening; or 3) no screening. We will then invite participants to a follow-up interview. We will ask participants
about their experiences with the preconception tools and how we can better incorporate preconception
screening and counseling into primary care settings. The findings from the quantitative pilot study will be
integrated with the qualitative data using an explanatory sequential joint display. This project’s results can
demonstrate the relevance of utilizing a quicker and potentially more effective preconception screening tool for
improving maternal and child health.

Public health relevance
Project Narrative Sixteen years have passed since the CDC recommended routine preconception screening and counseling in primary care settings, yet time constraints and low preconception counseling adherence have prevented widespread uptake. Our innovative, self-selected preconception screening tool encourages patients to be active participants in their own care and eliminates the time burden associated with typical pre-selected screening in clinics. This project will generate important knowledge about the promise of utilizing a patient-selected preconception screening tool to promote preconception health behavior change during routine medical encounters for women of reproductive age.